A Multisectoral Strategy to Address Persistent Drivers of the HIV Epidemic in East Africa

Project Summary
Progress towards HIV elimination will stall unless we overcome persistent drivers of new HIV infections by
jointly optimizing HIV treatment and effectively delivering HIV prevention modalities. We aim to determine how
to reduce HIV incidence to <0.1% using innovative strategies for HIV prevention and treatment to concurrently
reach “persistent driver” populations with scalable interventions optimized and evaluated in two phases.
• In Phase A (years 1-2), we will conduct individually randomized controlled trials (RCTs) to optimize the
following prevention and treatment packages: 1) Dynamic Choice HIV Prevention with flexible Pre-
exposure/post-exposure prophylaxis (PrEP/PEP) access integrated at family planning, antenatal care and
HIV clinics and at community Youth Hubs that generate demand by also offering provision of life-skills,
micro-finance and vocational training. 2) Dynamic Choice HIV Treatment with individual and system care
options and services tailored for youth, men, mobile populations, and heavy drinkers.
• In Phase B (years 3-5), we will test the hypothesis that a multi-sector intervention, offering dynamic choice
of biomedical HIV prevention and treatment for persistent driver populations will increase viral suppression
and prevention coverage and lead to a reduction in HIV incidence greater than standard of care.
Aim 1: Optimize dynamic prevention and treatment interventions: We will conduct RCTs of PrEP/PEP
dynamic prevention at multiple venues with high risk populations, and dynamic treatment interventions for
multiple populations with unsuppressed viral load. Primary efficacy outcomes (HIV prevention coverage and
viral suppression) will be used with implementation outcomes, costing, modelling projections, and stakeholder
input to optimize dynamic prevention and treatment intervention packages for Phase B.
Aim 2: a) Compare the effect of Dynamic Choice Prevention and Dynamic Choice Treatment
interventions vs. standard-of-care on prevention coverage, viral suppression, HIV incidence and
community health outcomes at 3 years. We will use a community randomized 2x2 factorial design to identify
effect of each intervention package and their combination on prevention coverage, viral suppression, and other
health outcomes. b) Elucidate pathways of intervention impact via evaluation of implementation and
process outcomes and of socio-behavioral pathways of action at the community, clinic, and individual levels.
Aim 3: Determine sustainability and inform policy. We will conduct multi-site costing of each aspect of the
multi-component intervention and estimate costs per HIV infection averted and impacts on multi-disease
disability-adjusted life-years (DALYs). Modelling incorporating study data will be used to inform stakeholders
on anticipated long-term health impact and costs of alternative prevention and treatment strategies.
Significance: This study will address major knowledge gaps on how to overcome key factors fueling the HIV
epidemic that inform stakeholders and guide policies towards accelerating the path to HIV elimination.

Public health relevance
Project Narrative The number of new HIV infections in Sub-Saharan Africa remain well above global elimination targets. The study aims to accelerate the path to HIV elimination with new innovative combination strategies for HIV prevention and treatment that are effective, efficient, scalable and reduce preventable infections and deaths.